Testing the effects of a selective calpain-2 inhibitor on spontaneous recurrent seizures in mouse models of epilepsy

Abstract
Epilepsy is the most prevalent neurological diseases after migraines. Current antiepileptic drug
treatments mainly attempt to reduce excitation or enhance inhibition in order to control seizures. Unfortunately,
such therapeutics result in a number of undesirable side-effects, and demonstrate limited efficacy against drug-
resistant cases of epilepsy. So far, no treatment has been developed as an anti-epileptogenic agent, in part
because of the limited understanding of the processes involved in the development of epilepsy. It is generally
accepted that up to 50% of all epileptic patients become epileptic as a result of a triggering initial injury such as
status epilepticus, stroke or traumatic brain injury. This initial triggering injury has been postulated to activate a
cascade of events leading to further seizures, increased brain damage and self-propagation. Intranasal delivery
of a variety of anti-epileptic drugs is increasingly used, as it provides significant advantages over traditional
delivery routes. These include increased efficacy, decreased side-effects and increased patient compliance,
suggesting that novel treatments could benefit from this mode of administration.
Calpains are a family of soluble calcium-dependent proteases, which have been implicated in epilepsy since
they are activated by seizures and participate in neuronal damage. Recent studies have also indicated that
during early epileptogenesis, seizure occurrence, calpain activity and neuronal damage are correlated, and that
treatment with a non-selective calpain inhibitor reduces the development of spontaneous recurrent seizures
(SRSs) in the pilocarpine model of epilepsy in rats. Our laboratory has demonstrated that calpain-1 and calpain-
2, two of the major calpain isoforms in the brain, have opposite functions in the brain. We have also found that
calpain-2 conditional knock-out mice with calpain-2 deletion in excitatory neurons from the forebrain show normal
seizure activity following injections of repeated low doses of kainic acid (KA) but exhibit no brain inflammation,
degeneration and impairment in hippocampus-dependent learning 7 days after seizures. Similar protective
results were obtained when wild-type mice were treated daily and for seven days after seizures with a selective
calpain-2 inhibitor, NA-112. These results strongly support the novel hypothesis that calpain-2 might represent
a potential therapeutic target to prevent various pathological consequences of seizures. This Phase I STTR is
directed at determining whether intranasal administration of NA-112, can prevent the appearance of SRSs or
reduce their frequency as well as prevent the various manifestations of neuropathology (brain inflammation,
neurodegeneration and cognitive impairment) in two mouse models of epilepsy, the repeated low doses of kainic
acid (KA) or of pilocarpine models. In Phase II of this STTR, we will further pursue the development of intranasal
delivery of NA-112 as an anti-epileptogenic drug. NeurAegis is a small biotech company focusing on the
development of selective calpain-2 inhibitors for the treatment of acute neuronal injury, including traumatic brain
injury and repeated concussions. This proposal is directed at expanding the potential applications of these
calpain-2 inhibitors by determining whether they could also be developed as potential therapeutic treatment for
epilepsy.

Public health relevance
A. Significance The significance is the same as in the original application. C. Approach C1. Specific Aim #1. To determine the optimal dose of NA-112 providing neuroprotection in two mouse models of epilepsy. C1.1. Rationale. We have selected two mouse models to evaluate the role of calpain-2 activation as the triggering mechanism in the development of epilepsy. No model perfectly reproduces all the features of the human disease; however, models provide critical information regarding the underlying mechanisms that could be targeted in the human disease. Repeated injections of low doses of KA or pilocarpine in C57Bl/6 mice will be used as models of epilepsy because they both lead to the appearance of SRS, are amenable to animal implantation with EEG-recording equipment and have a high degree of animal survival (11-12). We have shown that NA-112 is neuroprotective in the repeated low doses of KA mouse model and that intranasal NA-112 administration in mice results in brain calpain inhibition. This aim will determine the optimal dose of intranasal NA-112 providing neuroprotection in both models of epilepsy. C1.2. Preliminary Results C1.2.1. Effects of NA-112 in the repeated low doses of KA epilepsy model. We recently completed a series of experiments to determine the role of calpain-2 in the development of pathological manifestations of SE in mice. Our findings have been published in Neurobiology of Disease (9), and only a summary of the results is reported below. - KA model of epilepsy: All mice received three, consecutive, ip injections of kainic acid (5 mg/kg) every 20 min (10, 24) and were video-recorded for seizure analysis. - Mice: We used WT (C57BL/6J), calpain-2 conditional knockout (C2CKO, CamKII-Cre+/- CAPN2loxP/loxP) with deletion of calpain-2 in all excitatory neurons of the forebrain, and control (CAPN2loxP/loxP) mice. In addition, other groups of C57Bl/6J (WT) mice received daily ip injections of NA-112 (0.3 mg/kg/day) or vehicle (60 mg/kg/day of β-cyclodextrin) for 7 days starting 2 h after seizure initiation. - All mice exhibited SE and we did not observe any mortality with this protocol up to 7 days after KA-induced SE. There were no significant differences between any group for latency to first seizures, duration of first seizures and cumulative duration of stage 3-5 seizures. This is important, as it indicates that calpain-2 deletion or inhibition does not influence the initiation or duration of seizures, but rather the processes leading to neurodegeneration and neuroinflammation. - Seven days after seizure onset, numerous degenerating neurons were observed in hippocampus of WT animals, especially in the hilus of the dentate gyrus, identified as mossy cells; C2CKO mice were almost completely devoid of degeneration in all hippocampal subfields. Similar neuroprotective results were found when WT mice were treated daily with ip injections of NA-112. - Calpain-2 activation was detected in mossy cells up to 7 days after KA injection, and this activation was absent in C2CKO mice or in mice treated with NA-112. There was a clear correlation between calpain-2 activation in mossy cells with mossy cell death in WT mice. - KA-induced seizures resulted in strong astroglial and microglial activation in WT mice 7 days after KA-induced SE. Daily ip injections of NA-112 eliminated both astroglial and microglial activation. Similar results were found in the C2CKO mice. The prolonged duration of calpain-2 activation suggests that the window for intervention with a selective calpain-2 inhibitor following SE will be quite broad, although this will need to be further assessed in the Phase II of this STTR. - Cognitive performance was assessed by determining context-and tone-dependent memory in fear conditioning (FC) 7 days after seizure activity. Hippocampal-dependent contextual and tone memory was significantly impaired in WT and CAPN2 loxP (control) mice but not in C2CKO mice after seizures. Likewise, there was no significant impairment in mice treated daily with ip injections of NA-112. These results strongly support the premise that a selective calpain-2 inhibitor could be beneficial to prevent many of the neuropathological consequences of SE. - Blood P13BP levels are elevated after KA-induced seizures. We analyzed plasma levels of P13BP 24 h after KA-induced seizures (Fig. 1). P13BP blood levels were greatly elevated 24 h after KA-induced seizures in WT but not in C2CKO mice. Similar results were found in WT mice treated with NA-112 administered ip 3 h after SE (not shown). Figure 1: Plasma levels of P13BP 24 h after KA-induced seizures. Blood was collected 24 h after KA-induced seizures and aliquots of plasma processed for western blot analysis of PTPN13 (WES system). The fragment migrating at 150 kDa is referred to as P13BP and quantified. Results are means ± S.E.M. of 6 animals. *** p < 0.001; **** p < 0.0001. One way ANOVA followed by Bonferroni test. C1.2.2. Intranasal delivery of NA-112 inhibits brain calpain-2 activation. We tested the effects of intranasal administration of various does of NA-112 on calpain-2 activity in anasal NA-112 prevents KA-induced hippocampal calpain hippocampus 24 h after the administration (Fig. 2). Calpain-2 activation was completely prevented at the lowest activation in mice dose tested (0.1 mg/kg). Higher doses further decreased calpain- * 2 activation to levels lower than those seen in control conditions suggesting that NA-112 inhibits basal levels of calpain-2 activity. Figure 2: Intranasal NA-112 prevents KA-induced hippocampal calpain-2 activation in mice. Repeated low doses of KA (5 mg/kg) were administered to adult mice. NA-112 was administered intranasally 2 h after the end of seizure activity. Animals were sacrificed 24 h later and ‡ the hippocampus was dissected and processed for immunoblotting with ‡ a spectrin antibody. The ratios of SBDP/spectrin were analyzed. Results ‡ are means ± SEM of 4 experiments. Statistical analysis was performed vs control with ANOVA with post-hoc comparisons. * p< 0.001 vs cont. ‡ p < 0.01 1 vs KA vs KA. Cont KA KA+NA-112 KA+NA-112 KA+NA-112 (0.1 mg/kg) (0.3 mg/kg) (1.0 mg/kg) does of NA-112 on the plasma levels of ntranasal NA-112 potently prevents KA-induced increase in he pattern of results was very similar to plasma P13BP levels NA-112 prevents KA-induced increase in * BP in mice. Repeated low doses of KA (5 red to adult mice. NA-112 was administered the end of seizure activity. Animals were nd plasma was collected an processed for TPN13 antibody. The levels of the 130 kD esults are means ± SEM of 4 experiments. as performed with ANOVA with post-hoc 1 vs cont. ‡ p < 0.01 vs KA. ‡ ‡ ‡ *p< 0.001 vs control ‡ p < 0.001 vs KA C1.3. Design and Experimental Approach. These are identical to those presented in the original application. Rigor in experimental design and statistical analysis. All studies will be done in a blinded fashion, with the examiners analyzing the data blind to the experimental groups. Animal ID will be revealed after initial data analysis for group means and statistical analyses. All experiments will be performed with male and female mice. As mentioned above, there might be some differences for some of the outcome measures; in this case, data will be analyzed separately. When no obvious differences in outcome measures are observed, the data will be combined. The number of experiments we are proposing is based on our own as well as on previously published studies indicating it should be sufficient to detect significant differences between experimental groups. Statistical differences will be calculated with Student’s t-test when comparing 2 conditions. When comparing more than 2 conditions, ANOVA followed by Bonferroni tests will be used to determine statistical significance. Justification for the supplemental funding. This supplemental funding is requested to cover the additional cost to purchase the equipment needed to perform the proposed experiments, which is a combined video-EEG recording equipment from Biopac. As can be seen in the below email from Biopac, the original quote of $87,898 was missing some essential parts. These parts are essential for the completion of the experiments, and the fact they were not included in the initial quote was completely unexpected. At present, there is no fund in the current budget to cover this additional expense and we are already working with the minimum budget we need to complete the proposed experiments. From: Aimee Walker <[email]> Sent: Friday, August 25, 2023 11:35 AM To: 'Michel Baudry' <[email]> Subject: RE: Quote #99165 from BIOPAC Hi Dr. Baudry, WOW! Congratulations!! I just left you a voicemail, but give me a call when you have a moment so we can update your quote with current expiration dates, etc: 408-656-9287 The pricing is still the same as when we last connected, but I see a missing MP160 on the last version of the quote I sent in March (only 1 instead of 2). Did you submit the quote as it was or did you add in the second MP160 to your gran submission? Anyways, give me a call and we will sort it out. Looking forward to working with you on this! Aimee Walker – West Coast Sales Executive BIOPAC Systems, Inc. | 42 Aero Camino | Goleta, CA 93117 Tel: 805.685.0066 x 141 | Fax: 805-685-0067 Calendly: https://calendly.com/aimeew_biopac The original budget was indeed based on this quote. I am also providing below the original and the revised quotes. The difference in the quotes is $19,487.39, which is the requested budget. There is no overhead cost or fee associated with this supplemental budget, which is for an equipment, which will be purchased by the subcontractor, Western University of Health Sciences, and will remain there at the completion of the project.